Gene therapy targeting CFH and lipoprotein dynamics in AMD

Gene therapy targeting CFH and lipoprotein dynamics in AMD
ABSTRACT
Age-related macular degeneration (AMD) is the most common cause of irreversible blindness among the
elderly in industrialized countries, and there are no treatments for the majority of patients. Early hallmarks of
AMD are the formation of lipid- and protein-rich, extracellular sub-retinal pigmented epithelium (RPE) drusen
and basal laminar deposits that contain many constituents that are attributable to the activation of the
complement cascade and lipid metabolism. Complement and lipoprotein pathway genes have also been
independently associated with AMD through genetic risk association and epidemiological studies. Efforts to
understand contributions of lipid metabolism/trafficking and complement dysregulation to AMD pathogenesis
have been limited by the lack of age-dependent in vivo models that recapitulate these features of the disease.
The aim of the proposed studies is to leverage data derived from novel animal models of AMD that we
have developed. These models integrate advanced age, complement dysregulation and lipid/cholesterol
perturbation, all known contributors to human AMD risk. Specifically, we generated mouse models based on
the most replicated genetic risk variant associated with AMD risk, the tyrosine (Y) to histidine (H) substitution at
amino acid position 402 (Y402H) of human complement factor H (CFH), the soluble regulator of the alternative
complement pathway. Only mice expressing the human H402 AMD risk variant (CFH-H/H) develop an AMD
phenotype compared to mice expressing the normal human Y402 CFH variant. Significantly, the AMD
phenotype correlates with lipoprotein level changes in blood and in the RPE/Bruch’s membrane (BrM)/choroid
complex. Thus, we are the first to observe a functional consequence of the Y402H polymorphism in vivo, which
promotes an AMD-like pathology and affects lipoprotein levels in aged mice. Our analysis of ApoA-I containing
lipoproteins isolated from BrM and plasma of elderly human donors found that these tissues have very different
protein compositions. The most striking difference is the significantly higher concentration of ApoB and ApoE in
BrM, which are known to bind to glycosaminoglycans (GAGs) and could promote lipoprotein deposition onto
BrM GAGs; likely initiating downstream effects that contribute to RPE dysfunction/death. Based on these
observations and other studies we hypothesize that aberrant RPE-derived high-density lipoprotein (HDL)-like
secretion contributes to AMD development and is modulated by CFH.
The goals of the proposed studies are to use our novel animal models of AMD and human RPE to test the
extent to which AAV-gene therapies augmenting normal CFH and/or enhancing local HDL clearance are viable
strategies for treating AMD. Outcomes from these studies will mechanistically determine the interaction of two
risk factors, CFH and lipoproteins in AMD and provide preclinical evidence for these factors as therapeutic
targets for AMD.

Public health relevance
PROJECT NARRATIVE (Public Health Relevance Statement) Age-related macular degeneration (AMD) is the leading cause of irreversible blindness among elderly Americans, which has a devastating socioeconomic burden, particularly since there is currently no cure. Our proposed studies are designed to (1) establish preclinical efficacy of a lipid metabolism modulator and of a complement regulator to treat AMD and (2) mechanistically determine the interaction of two crucial pathways regulating the complement system and lipid metabolism and their interplay in the development and progression of AMD. The proposed research is relevant to the National Eye Institute high priority research area, From Genes to Disease Mechanism, which includes mechanistically understanding the impact of aging on eye disease and optimizing gene-based therapies.